Neurologic Oncology Program

Neurologic Oncology Program: Summary/Abstract
The overarching scientific goal of the HDFCCC Neurologic Oncology (NE) Program is to use a team approach
to advance the understanding of brain tumor biology and drive translation toward more effective and targeted
treatments. This is achieved through the close collaboration of multidisciplinary clinicians and scientists
devoted to studying brain tumors and combine expertise in genomics, cell signaling, developmental biology,
immunotherapy, neuroimaging, epidemiology, and molecular therapeutics. A major goal of the NE Program is
to more effectively move promising discoveries from the lab into clinical trials by strengthening relationships
with clinical trials consortia, government agencies, and industry. All activities of the NE Program reflect the
HDFCCC’s cross-cutting Themes of Impactful Discovery (Theme 1); Effective Translation (Theme 2); and
Implementation and Dissemination (Theme 3) (see Director’s Overview), and are bolstered by the resources
and collaborative environment provided by the HDFCCC. Specifically, NE member research focuses on (1)
improving the understanding of the underlying biology of brain tumors; predicting patient disease, response,
and survival in brain cancers; and (3) improving therapy for brain tumors.